Training Grant in Academic Endocrinology

This is a 5-year renewal application to support 5 postdoctoral trainees for a broad Training Program in Academic
Endocrinology. This program has been in place at the Brigham and Women’s Hospital/Harvard Medical School
since 1985 and has been highly successful in training physician-scientists and basic scientists, many of whom
remain in academic endocrinology. In the last 15-year period, 80% of the 30 trainees who have completed their
training remain in a research career. The faculty combines both physician-scientists of the Endocrinology
Division with those basic scientists of the Harvard Medical School faculty whose research is significantly related
to endocrinology and who have a past and current history of collaborative interactions with Program faculty
members in the Endocrinology Division. These 23 faculty members have collectively trained 475 postdoctoral
fellows, the great majority of whom remain in research-related careers, either in academic positions or in industry.
The 5 trainees appointed each year will be individuals with MD, PhD, or MD/PhD degrees and they will undertake
3-4 years of an intensive research experience with an emphasis on translational investigation. The goal of the
program is to provide structured and mentored training experiences to afford trainees with sufficient expertise to
apply successfully for mentored research awards, such as K23, K08, K01 or K99 awards, or independent
research grants such as R01 grants, to ultimately develop into translational endocrine investigators who will
address the great needs for research into endocrine and metabolic disorders that are so prevalent and cause
such great morbidity in our society. The diverse areas of research interest of the faculty span endocrine science
from the molecular and cellular levels to whole animal, patient-oriented and population levels, encompassing
regulation of energy expenditure, insulin signaling, mechanisms of steroid and thyroid hormone action,
neuroendocrinology, the control of skeletal muscle development, differentiation, and repair, and the epidemiology
of diabetes, obesity, and vitamin D deficiency disorders. There is a strong emphasis on genetics, epigenetics,
and new technologies for translating science into therapeutics. Individuals in this program will be trained to
translate the insights they gain to develop strategies for the treatment and prevention of common endocrinology-
based public health problems, including diabetes, obesity and osteoporosis.

Public health relevance
This Training Program in Academic Endocrinology assembles a group of outstanding clinical and basic scientists to oversee the training of fellows with an interest in understanding the mechanism and regulation of hormone effects and how they are disrupted to produce clinical disorders. The core goal of this Training Program is to train scientists and physician-scientists in diverse aspects of the field of endocrinology, with an overarching emphasis on translational research. Fellows will be trained in fundamental research techniques in order to contribute to the understanding and treatment of major endocrine disorders, such as obesity, diabetes, and osteoporosis.